Complementary Mechanisms of Protection Against Pneumococcal Infection

A leading cause of pneumonia and related morbidity and mortality is the mucosal pathogen, Streptococcus
pneumoniae. Beginning at the upper respiratory mucosa, infection begins with colonization which can then be
complicated by pneumonia and invasive bloodstream infections. The most prominent antibody in these
mucosal sites is the IgA1 subclass. IgA1 antibodies to the pneumococcal capsule, its primary virulence factor,
are generated in response to colonization, symptomatic infection and vaccination. The variable region of IgA1
binds to the organism and the constant region binds to phagocytes (e.g., alveolar macrophages and
neutrophils). A pneumococcal enzyme, IgA1 protease, is expressed on the surface of the bacteria. IgA1 bound
to the capsule is cleaved by the protease at the bridging hinge between the variable and constant region,
thereby inhibiting the ability of IgA1 to support phagocytosis, killing and clearance of the organism. Residual
variable regions that remain on the surface modify the bacteria's surface and enhance binding to epithelial cell
receptors, likely promoting colonization with the organism. This subversion of the protective host response to
S. pneumoniae predisposes older veterans to increased risk for serious infection.
Preventing the bacteria's inactivation of the host's response can be achieved by a subset of patients with
invasive pneumococcal disease who generate IgG in serum that neutralizes the protease's ability to cleave
IgA. Moreover, we have generated murine monoclonal antibodies (mMabs) that bind and some neutralize the
protease. We propose to advance our understanding of the structure-function relationships of the protease
and consider the feasibility of advancing this protein as a primary or adjunctive vaccine candidate. In this
context, we Hypothesize that:
1) Neutralizing antibodies to IgA1 protease recognize conserved epitopes on the enzyme.
2) Protease-neutralizing antibodies with human IgA1 and prevent epithelial cell binding in
vitro and colonization with intranasal challenge in vivo by inhibition of IgA1 cleavage.
3) Antibodies to IgA1 protease protect mice against fatal mucosal infection with S. pneumoniae indirectly by
inhibiting cleavage of human IgA1 bound to the bacterial surface and directly by surface binding and
mediating phagocytosis of the organism.
To address these Hypotheses, we propose to pursue the following Specific Aims:
Aim 1. Characterize the epitopes targeted by protease-neutralizing monoclonal antibodies (Mabs) and their
genetic conservation.
Aim 2. Characterize the epitopes targeted by protease-neutralizing monoclonal antibodies (Mabs) and their
genetic conservation.
Aim 3. Determine the ability of protease-specific Mab's to protect against fatal infection after mucosal
challenge in vivo and the mechanisms underlying protection.
This work is directed to determine the targets of the protease-neutralizing antibodies, the geographic and
molecular diversity of pneumococcal proteases to consider the generalizability of these investigations, and the
ability of protease binding and neutralization on IgA1 effector functions to prevent colonization and to support
phagocytosis and killing of S. pneumoniae both in vitro and in vivo in mouse models. These studies provide
important basic and pre-clinical data for considering the role of the protease in vaccine disease prevention and,
potentially, therapy.

Public health relevance
The most common cause of serious bacterial pneumonia in veterans is Streptococcus pneumoniae (the pneumococcus). The bacteria begins with mucosal infection of the upper respiratory tract, can then be inhaled into the lungs to cause pneumonia, with the potential to invade into the bloodstream. Each level of infection is associated with increasing frequencies of morbidity and mortality. Akin to multiple other invasive human respiratory pathogens in humans, the pneumococcus consistently produces a protease that cleaves and inactivates the predominant antibody in the respiratory tract, IgA1. We propose that antibodies to the protease enhance protection by complementary mechanisms, both indirectly by inhibiting cleavage of protective IgA by the protease and directly by supporting killing of S. pneumoniae, providing a novel and promising vaccine approach to prevent pneumococcal pneumonia and disease.